Neuroimaging biomarkers for sense of control, catastrophic expectations, and stress reactivity as novel treatment targets for functional seizures.

Project Summary/Abstract
Functional seizures (FS) are a subtype of Functional Neurological Disorder (FND). FS are paroxysmal attacks
resembling epileptic seizures, but without corresponding epileptiform activity in the brain. They account for at
least 20% of new epilepsy evaluations and negatively affect independence, employability, and caregiver
wellbeing. FND as a whole cost the U.S. healthcare system $1.2 billion annually. Despite their significant
prevalence and burden, there are no validated treatments for FS. Research has suggested that sense of
control over physical symptoms, catastrophic symptom expectations, and stress reactivity may be possible
novel treatment targets for reducing FS. Sense of control is the extent to which a person perceives they are in
control, and is impaired in patients with FS because symptoms are perceived as involuntary. Catastrophic
symptom expectations are expressed as both a tendency to interpret normal physical sensations as
threatening (i.e., indicating disease) and a tendency to over-estimate the likelihood that threatening symptoms
will occur, which can themselves induce the feared symptoms. Heightened stress reactivity stems from
defective emotion regulation abilities and confers vulnerability for several mental health conditions, including
FS. Objective outcome measures for these endpoints have not been established in this population, which limits
our ability to assess the effectiveness of FS interventions. Thus, the proposed project aims to develop
objective neuroimaging-based outcome measures for the above targets. We will use functional magnetic
resonance imaging (fMRI) to examine neural activity in brain regions associated with emotion processing and
control, including the prefrontal cortex, cingulate, insula, hippocampus, and amygdala. Forty adults with FS and
40 controls matched on age, sex, and Psychiatric comorbidities will undergo fMRI while completing two tasks:
the Threat Predictability and Controllability Task (TPCT) will assess neural responses to controllable vs.
uncontrollable and predictable vs. unpredictable threats, and the Montreal Imaging Stress Task (MIST) will
measure neural responses to performance demand stress (induced via challenging mental arithmetic) and
social evaluative stress (induced via negative auditory feedback). We will also collect expectancy ratings prior
to threat presentation on the TPCT to assess potential biases in threat anticipation in FS compared to controls.
Uncovering the neural substrates of abnormal behavior in FS will enhance our understanding of FS
pathophysiology and provide critical tools to improve interventions for this condition. This Mentored Career
Development Award will provide opportunities to acquire skills in fMRI experimental design, data acquisition,
and analysis; acquire knowledge of conditioning paradigms relevant to FS development and treatment; and
participate in career development activities including grant writing, lab management, and networking. The
award will allow me to transition my research program to the field of FND and meet my long-term career goal
of becoming an independent investigator.

Public health relevance
Project Narrative Functional seizures, a subtype of Functional Neurological Disorder, are paroxysmal attacks without epileptic activity in the brain that are associated with significant impairments in functioning, employability, and increased healthcare utilization. Impaired sense of control, catastrophic symptom expectations, and increased stress reactivity have emerged as novel treatment targets for functional seizures, but they cannot be evaluated in clinical trials because they lack objective outcome measures. The proposed study will develop neuroimaging-based outcome measures for these targets by comparing neural reactivity on the Threat Predictability and Controllability Task and the Montreal Imaging Stress Task during functional magnetic resonance imaging between patients with functional seizures and matched controls.